Five Point Initiative: A Cluster Randomized Trial of a Bundled Implementation Strategy to Address the HIV Epidemic in Black Communities

Background: While Black individuals make up 16% of the population in Miami, FL (an epicenter) they account for 29%
of new HIV diagnoses3 linked to structural racism, other isms, and their manifestations. Manifestations of structural
racism include healthcare desserts, barriers to access care (i.e., distance, transportation, finances), discrimination, and
medical mistrust that thwart HIV testing and prophylaxis (PrEP) uptake.47-49 Preliminary work. Our Five Point Initiative
(FPI) is a locally developed bundled implementation strategy (BIS) to expand the reach of evidence-based clinical
interventions (i.e., HIV testing, PrEP, condoms) to Black communities that harnesses partnerships with community HIV
experts, local businesses, and federally funded community health organizations, removes barriers to access by going to
communities, and enhances trust through racial/cultural competence and lived expertise.35-36 Successful 1-Year
Planning EHE Supplement (2019-2020). We built partnerships across 4 HIV high impact zip codes (13 businesses, 5
health partners, 10 events), piloted the approach (e.g., HIV testing was optional), and engaged residents (N=677).
Successful 2-Year EHE Implementation Supplement (2020-2022). We refined FPI BIS, reached 1,887 community
members who are not reached by standard public health approach (64% no knowledge of PrEP, only 4% prescribed
PrEP, 46% HIV test > 12 mons; 40% condomless sex past 3 mons), required HIV testing (90% [4% reactive]), provided
PrEP information (100%) and linkage (22%), and expanded the reach (13 high impact zip codes, 73 businesses, 54
events, and 8 health partners). Conceptual Model: This hybrid implementation trial type 2 proposal is guided by the
Reach Effectiveness Adoption Implementation Maintenance framework (RE-AIM) to evaluate the FPI implementation
strategy. Research Plan: Via a cluster stepped wedged RCT we will randomly introduce 8 HIV high impact zip codes in
Miami, FL to the FPI intervention (2 outreach events per month over 21 months [42 total events per zip code]). We will:
(1) Assess whether the FPI intervention has a significant increase at the community level on (i) HIV testing (primary), (ii)
PrEP linkage/prescription (primary) and knowledge, and (iii) condom access/use. Outcomes i-iii will be assessed via
(a) pre-intervention surveys (n=225 residents per 8 zip codes: 1800 residents total) and post-intervention assessments
(n=225 residents per 8 zip code: 1800 residents total) (b) data from FPI intervention events, and (c) administrative data
from publicly funded health partners during non-intervention (pre- & post- FPI intervention) periods. (2) FPI and health
partner administrative data will be used to assess (2a) how effective FPI BIS is at engaging Black residents in HIV testing
and PrEP linkage (reach), (2b) describe among whom (adoption) and how (fidelity, adaptations, costs) the FPI
intervention was implemented, and (2c) assess sustainability via survey and periodic reflections with implementation
partners (maintenance). (3) Conduct spatial analysis to examine if the FPI intervention in zip codes randomized to the
intervention explains variations in the outcomes (Aim 1 i– iii; Aim 2a) and HIV base rates for neighboring zip codes who
did not receive the intervention. Implications: Assessing effectiveness and implementation outcomes of FPI may equip
us with a bundled strategy to increase HIV testing and PrEP uptake among Black and other minoritized communities.

Public health relevance
Project Narrative Black communities are disproportionally impacted by HIV, in the U.S. in general and in Miami, FL (a southern HIV epicenter) and in our quest to end the HIV epidemic we need to utilize community-driven implementation strategies centering Black individuals and tackling manifestations of structural racism. Our Five Point Initiative (FPI) (a) is a locally developed bundled implementation strategy, (b) harnesses the combined efforts of community experts, businesses, and health organizations, and (c) demonstrates strong evidence of acceptability and feasibility via our 1-year and 2-year Ending the HIV Epidemic (EHE) supplements. Building on an established network with over 80 local businesses, 8 community health organizations, and community HIV experts with unmatched expertise, our proposed study will conduct a stepped wedge cluster randomized trial to test the effectiveness of the FPI implementation strategy in increasing HIV testing, PrEP linkage (e.g., prescription) and knowledge, and condom access/use among Black residents in HIV high impact zip codes.